The function of TWIST1 acetylation in cell fate and tissue development

Abstract
Craniofacial disorders are the second most common congenital birth defects, while pediatric cancers are the
leading cause of death in children. These anomalies arise from a disruption in regulating neural tube (NT) and
cranial neural crest cell (CNCC) development. Despite the high prevalence, significant gaps remain in our
knowledge of the genetic risk factors and the underlying mechanisms that lead to these disorders. We have
recently identified a novel function of Twist1 in the neural tube and CNCC fate transition. Our recent findings
showed that Twist1 is involved in cell shape changes during NT closure and suppresses epithelial genes during
the epithelial-to-mesenchymal transition (EMT) of pre-migratory CNCCs to become migratory mesenchymal
cells. In addition, our supporting data indicates that TWIST1 is acetylated at K73; K76 in cancer cells, and the
di-acetylated K73Ac;K76Ac enables TWIST1 to interact with histone acetyl-transferase factors, BRD8, p400,
EPC1, and TIP60, which are members of the NuA4 complex, in cancer cells. To follow up on our findings, the
Xu lab at Baylor College of Medicine (BCM) will establish a new collaboration with Fakhouri lab at UTHealth
School of Dentistry to determine the novel significance of TWIST1 acetylation in the development and CNCC-
derived tumor formation. For this collaborative project, we hypothesize that TWIST1 acetylation is necessary to
dictate the interaction with chromatin modifying factors to control cell fate determination during craniofacial
development and CNCC-derived tissue differentiation. To test this high-risk, high-reward hypothesis, we will
generate acetylated-incompetent (K73A; K76A), acetylated-mimic (K73Q; K76Q), and deacetylated-
mimic/incompetent (K73R; K76R) mouse lines and genetically-modified O9-1 CNCC lines with similar point-
mutations. The phenotypical, histological, and cellular analyses of the mouse lines will assess the function of
TWIST1 acetylation in tissue development and potentially CNCC-derived tumor formation. We will investigate
TWIST1 acetylation and CNCC differentiation capacity in O9-1 stable lines. This project aims to: (1) Uncover
the function of TWIST1 acetylation in craniofacial development and tumor formation, (2) Investigate the
interaction between TWIST1 and NuA4 chromatin modifying complex and their involvement in CNCC
differentiation capacity. We will determine the impact of Twist1 acetylated-incompetent (K73A/R; K76A/R) and
acetylated-mimic (K73A; K76A) mouse lines on NT closure, fate transition in pre-migratory CNCCs, and CNCC-
derived tumor formation. We will examine in O9-1 CNCC line the significance of interaction with the members of
NuA4 chromatin-modifying complex, and O9-1 CNCC migratory and differentiation capacity. This project will
provide a tremendous opportunity to establish a cross-disciplinary collaboration that will leverage our
complementary strengths in mouse genetics, craniofacial development, and cancer biology.

Public health relevance
Project Narrative (PUBLIC HEALTH RELEVANCE STATEMENT) Craniofacial birth defects and pediatric cancer occur due to genetic alterations and environmental conditions that disrupt the proper development of embryonic tissues. Therefore, identifying causative factors and disrupted regulatory pathways essential in controlling cell fate is crucial for developing accurate disease risk assessment and small molecules for targeted therapeutic approaches.